Integrated Training in Anesthesiology Research

The goal of this program is to provide postdoctoral fellows with research training enabling them
to develop independent investigative careers devoted to improving care of the
anesthetized/critically ill/chronic pain patient by advancing scientiific knowledge in the field. The
Department of Anesthesiology at Duke University Medical Center has intensively invested its
resources in the development of multidisciplinary laboratory and clinical research environments
to offer state-of-the-art research training experiences. We have also innovated in
anesthesiology residency training to provide a research continuum that provides a highly
effective preparatory phase prior to T32 enrollment. This proposal outlines the credentials of a
distinguished training faculty who are willing and prepared to meet our goal. The training
program involves a 2-3 year continuum when the trainees work under the close and direct
supervision of a program faculty member on research projects of mutual interest. Emphasis is
placed on learning responsible research skills, achieving mastery of the literature, independent
hypothesis generation, experimental design, data analysis, presentation and publication of
research findings and competition for extramural funding. All trainees are encouraged to exploit
relationships established with members of the program faculty for both enrichment of research
skill repertoires and development of long-term collaborative relationships. The program is
directed by the Program Director and an Oversight Committee consisting of 8 senior scientists
and the departmental chair. Trainees formally report to the program leadership at quarterly
intervals to allow assessment of trainee performance and progress in achieving program goals.
Trainees are sought from a national pool of eligible candidates with emphasis placed on
recruitment of under-represented minority trainees. The primary focus of this program is the
research training of select post-doctoral fellows. However, the program also is the cornerstone
of our departmental research training endeavor setting high standards for investigative training
offered to medical students, residents, junior faculty, and visiting scholars who participate in the
research training process.

Public health relevance
This program is designed to provide intensive training in research relevant to patients requiring anesthesia, critical care, and/or pain intervention. Provision of the next generation of physician- scientists will serve to improve medical care based on acquisition of scientific evidence and better understanding of relevant disease states.